Personal tumor neoantigens for immunity against chronic lymphocytic leukemia

Project Summary
Personal neoantigens have been conceptualized as optimal tumor antigens but their broad applicability across
cancers has been limited by the variability in mutational burden across tumors. Recent clinical experiences in
targeting neoantigens, such as by vaccination, in high and moderate mutation-rate tumors (e.g. melanoma,
glioblastoma) have been promising, but such promise for low mutation burden cancers remains under evaluation.
Chronic lymphocytic leukemia (CLL) is an example of such a low mutation burden malignancy where improved
tumor antigen identification could open new therapeutic opportunities. Indeed, although a growing
armamentarium of clinically active therapies is now available for CLL (i.e. targeted inhibitors, CAR-T cells, CPB),
CLL remains largely incurable. While inherently immunogenic, as highlighted by evidence of spontaneous
regression and its responsiveness to the graft-versus-leukemia (GvL) activity of allogeneic hematopoietic cell
transplantation (allo-HCT), CLL patients demonstrate inconsistent ability to mount antigen-specific immunity.
Notably, we have achieved several exciting technologic advances over the last 5 years that impact antigen
discovery, including: (i) new understanding of the cancer genome and transcriptome, advanced by new
sequencing technologies, yielding potential alternative sources of cancer neoantigens; (ii) establishment of a
scalable approach to rapidly validate peptide-MHC interactions, providing essential experimental feedback to
our prediction efforts; (iii) improvements in the sensitivity, throughput and analysis of immunopeptidome data;
(iv) expanded computational infrastructure to rapidly incorporate findings into prediction models for HLA class I.
In this application, we hypothesize that novel classes of neoantigens are discoverable in CLL and that
antigen-specific interactions arising from recognition of these alternative neoantigens could contribute
to leukemia control. We propose an integrative strategy for the discovery and validation of novel neoantigen
species. This commences with detection analyses of alterations that could encode these alternative CLL
neoantigens through long-read and ribosomal sequencing, that can be used to inform improvements on the
analysis pipelines. It then proceeds with validation using new high throughput binding assays, immunopeptidome
detection and T cell response assessments (Aim 1). Our strategy further involves systematic improvement of
our class I prediction tools through generation of experimental data from which we can iteratively correct and
refine the epitope predictions. We furthermore incorporate the feature of peptide-MHC stability, which has been
increasingly identified as relevant in peptide-MHC immunogenicity (Aim 2). Finally, we propose to confirm the
functional relevance of alternative tumor neoantigens through their evaluation in the context of variation in natural
history of CLL in a newly-assembled cohort of >1000 molecularly characterized samples, and within the setting
of therapeutic response following whole CLL cell vaccination after alloHCT (Aim 3). We thus propose to expand
the ‘universe’ of CLL neoantigens and to define their impact within informative clinically annotated CLL datasets.

Public health relevance
Narrative Cancer immunotherapy has been demonstrated to provide remarkable clinical benefit, and a contributor to this benefit is thought to be the high number of cancer mutations, present in some cancers, which can produce surface molecules called mutated peptides that can stimulate tumor-specific immune responses. However, for many cancers like chronic lymphocytic leukemia (CLL), the number of cancer mutations that are detected through standard methods is low, but a growing body of evidence suggest that these types of blood cancers have many alternative types of molecular changes that can still generate targets recognizable by the immune system. We propose to build an integrated program using innovative genomic technologies and mass spectrometry to better detect these new classes of patient-specific mutated peptides, to develop predictive tools for their identification, and then to apply these new tools to better understand how immune responses to these mutated peptides shape the clinical history of CLL and its response to immunotherapy exposure.